Developing a new drug for treating myocardial ischemia/reperfusion injury

Myocardial infarction (MI) is a prominent manifestation of heart disease with very high mortality. Despite the
great success of surgical and intravascular interventions and thrombolytic therapies, MI mortality remains high
and a significant percentage of MI survivors suffer from heart failure. Thus, there is a strong need and large
market for new drugs to further reduce mortality and to treat post-MI heart failure. Treatment of MI requires
timely reopening of the blocked coronary artery and reperfusion of the ischemic tissue. However, reperfusion
itself may induce myocardial ischemia/reperfusion (MI/R) injury, which increases cardiac damage and mortality.
It was shown that inflammation, consequent vascular leakage and microvascular thrombosis all play critical
roles in MI/R injury. Anti-platelet drugs are routinely used in acute MI patients, mainly for the prevention of
secondary thromboses or stent thrombosis. As microvascular thrombosis is a key factor in MI/R injury, anti-
platelet drugs, in theory, should be protective. However, although anti-platelet treatment improves MI outcome
in general, the more potent and fast-onset intravenous anti-platelet drugs, when used on top of mild and slow-
acting oral anti-platelet drugs, are not significantly more effective in improving MI outcome than oral anti-
platelet drugs alone. As the increased potency of the current anti-platelet drugs is associated with increased
adverse effect of causing vascular leakage and bleeding, which are also important factors in MI/R injury, we
hypothesize that these adverse effects may limit the efficacy of anti-platelet drugs in treating MI/R injury. Based
on our new concept (Gong et al Science 2010, Shen et al, Nature 2013) that G13-dependent outside-in
signaling of the platelet integrin IIb3 (GPIIb-IIIa) is selectively important in occlusive thrombosis but not
hemostasis, we designed a peptide inhibitor of the G13-integrin interaction, M3mP6, and a novel high-loading
peptide nanoparticle (HLPN) formulation for in vivo intracellular peptide delivery. In proof-of-concept studies,
we have demonstrated that M3mP6 HLPN potently inhibits occlusive intravascular thrombosis without causing
bleeding. Importantly, M3mP6 also has anti-inflammatory effects mediated by inhibition of 2-G13 binding in
leukocytes, thereby reducing neutrophil function. M3mP6 had a striking therapeutic effect in treating MI/R
injury in a mouse model. Pilot toxicology studies carried out with M3mP6 HLPN showed no toxicity. Based on
these exciting new data, we propose in this direct Phase II SBIR application to further develop this novel drug
from the proof-of-concept stage to IND for the treatment MI/R injury and prevention of post-MI heart failure.
Our specific aims are (1) to compare the effect of M3mP6 HLPN to current standard anti-platelet therapy as
well as their additive effects in treating MI/R injury and preventing post-MI heart failure in animal models. (2) to
further evaluate the adverse effect of bleeding and toxicity of M3mP6 HLPN with and without current anti-
platelet therapy. (3) Develop drug scale-up methods and prepare for IND submission. If successful, this new
drug should have a major impact in further improving MI survival and reducing post-MI heart failure.

Public health relevance
Despite the great success in treating heart attacks by unblocking the coronary artery supplying blood to the heart, mortality from heart attacks remains high and a significant percentage of survivors suffer from heart failure, mainly because re-establishment of the flow of fresh blood into the ischemic heart may itself induce inflammation, which causes leakage of blood vessels, thrombosis (clotting), and further damage to the heart (called myocardial ischemia-reperfusion (MI/R) injury). Because current treatments have limited effectiveness due to bleeding side effects and lack of anti-inflammatory properties, we have invented a new drug that blocks both thrombosis and inflammation without causing bleeding, and demonstrated its efficacy in treating MI/R injury in animal models. In this application, we propose to further test the efficacy and safety of this new drug and develop it for the clinical treatment of heart attacks and MI/R injury to improve survival and reduce post-MI heart failure.